c-MYB overexpression for exhaustion resistant CAR-T cell therapies

SUMMARY
Chimeric Antigen Receptor or CAR-T cells are curative in various hematologic malignancies, with six products
obtaining FDA approval since 2017. However, the same mechanisms that enable high therapeutic efficacy in
some patients can lead to overstimulation and functional exhaustion of the CAR-T cell therapy, resulting in par-
tial remission and/or disease relapse. Technologies that limit CAR-T cell exhaustion are likely to improve thera-
peutic outcomes by promoting anti-tumor functionality and enhancing the duration of therapeutic activity. In
mice, T cells engineered to overexpress specific transcription factors have enhanced anti-tumor activity by lim-
iting exhaustion. However, when considering CAR-T cells for human therapeutics, fine-tuning the expression of
factors that regulate transcriptional reprogramming events to curtail exhaustion while maintaining anti-tumor
functionality is not easily addressed with current methods of cellular programming.
This proposal is focused on overexpressing the transcription factor c-MYB as part of the response of this grant
to NOSI NOT-NS-22-017 in CAR-T cell therapy for enhanced therapeutic efficacy. Critical to our ability to de-
velop optimal CAR-T cells with this approach, we use proprietary precision gene editing technology, Ge-
neWeld. GeneWeld permits the precise, reproducible integration of multi-kilobase cargo DNA into loci with
base-pair precision, thus permitting improved expression of multiple cassettes for the development and ad-
vancement of human cell therapy manufacturing. This Phase I proposal is focused on demonstrating the feasi-
bility of producing c-MYB-enforced CAR-T cells that provide sustained anti-tumor activity, ultimately resulting in
clinical improvements over the current FDA-approved CAR-T cell therapies.

Public health relevance
NARRATIVE Therapeutic failures of CAR-T cells are in large part due to T cell exhaustion. This proposal is focused on demonstrating the feasibility of NIH-patented technology US11098283B2, which will be licensed by LEAH Labs as part of the response to grant RFP NOSI NOT-NS-22-017, in generating CAR-T cells with enhanced anti-tu- mor functionality by overcoming exhaustion. Specifically, the ability of c-MYB to directly modulate transcrip- tional programs that promote stem-like memory T cell formation while limiting terminal differentiation will result in more effective CAR-T cell therapies.